Administrative Core

PROJECT SUMMARY/ABSTRACT
The UAB Cystic Fibrosis Research and Translation Core Center Administrative Core is
responsible for the overall administration and coordination of the Biomedical Research Cores,
Pilot & Feasibility Program, and Enrichment Program. Directed by Drs. Rowe (P01 Director) and
Bedwell (Associate Director) with assistance from the experienced Research Management and
Administrative Team—including Ms. Jamie Elliot, Center Business Officer and Dr. Emily Falk-
Libby, Program Director-Scientific Affairs—the Core will continue to successfully support CF
Center goals in the upcoming funding cycle by: 1) Establishing the overall scientific direction of
the UAB P30 CF Center (e.g., directing communications between the Administrative Core, P01
investigators, members of the Center's active Internal Advisory Board, and/or external
consultants on its External Advisory Board to review Center activities and identify research
directions and opportunities), 2) Facilitating the objectives of all P30 components (e.g.,
optimizing Core resources for optimal utilization, coordinating training and professional
development activities, maintaining a Center website, overseeing membership, building the
Biomedical Core research base and monitoring its productivity), and 3) Integrating P30
components with other UAB NIH Centers (e.g., promoting and sharing its innovative resources
and communicating with other Center leadership such as the Center for Clinical and
Translational Science (UAB's CTSA site), NIDDK-Diabetes Research and Training Center, and
NIDDK-Nutrition Obesity Research Center) to identify continued opportunities for
multidisciplinary collaboration. In addition, specifically in support of the Center's Enrichment and
Pilot & Feasibility Programs, the Administrative Core will continue to identify and integrate
resources offered through the Institution to maximize trainee success and transition to
independence for junior faculty as well as to apply its established, robust mechanisms for
solicitation, review, and oversight of P30 pilot applications to foster new and important
contributions to CF science. Overall, it is the goal of the Administrative Core to optimally
promote synergy and progress within the CF P30 Center.